Stanford K12 Clinician-Scientist Career Development Program

PROGRAM SUMMARY / ABSTRACT
Objective: The principal mission of the Stanford K12 Clinician-Scientist Career Development Program is to
fund a premier clinician-scientist/clinician investigator training program, designed to leverage excellence in
basic, translational and clinical research to develop new clinician-scientists who will emerge as productive,
independent physician scientists and strong leaders across the eye and vision research community.
Rationale & Design: Through this institutional career development award, we will incorporate a rigorous
program with outstanding vision research faculty serving in various mentor and supervisor roles,
comprehensive eye and vision courses, and significant clinical ophthalmologic exposure to facilitate future
applications of vision research. The Byers Eye Institute along with the broader vision research community at
Stanford University has a proven record of success in mentoring, along with sufficient external support to
support all scholars.
Key Activities in the Training Plan: In this program, participating faculty will lend their expertise by serving
across Mentoring Groups, an Executive Committee, and an External Advisory Board to help build, review and
support each Scholar's career development plan. As recent K-awardees, additional junior faculty will also serve
in the Near-Peer Mentoring Committee to lend additional advice and guidance and build a community of
mutual support for Scholars. Scholars will be partnered with mentors appropriate to their scientific focus and
will be trained in basic or clinically relevant research, as well as additional essential skills meant to propel their
transition to independence, such as statistics, scientific writing, grantsmanship, ethics, leadership and the
responsible conduct of research. Each program will be customized for each Scholar according to their specific
interests, skills and background, needs, and career goals.
Planned duration of appointments and projected number of scholars: With an emphasis on recruiting
strong applications from women and under-represented minority applicants, a maximum of 3 postdoctoral
Scholars will be selected each year after their completion of a post-residency clinical fellowship in
ophthalmology. K12 Scholars will typically spend 2 years in the program.
Intended scholar outcomes: Successful outcomes will be measured by productivity in papers and
presentations, successful transition to independent K awards and later conversion to R-funded research, and
impact on the field of eye and vision research as well as clinical ophthalmology. Stanford has robust mentoring
systems, strong curriculum, and solid infrastructure in place to prepare Scholars for research independence.
Together, the program's myriad resources will create a supportive environment for K12 Scholars throughout
the duration of the program.

Public health relevance
PROJECT NARRATIVE The Stanford K12 Clinician-Scientist Career Development Program will offer junior clinician investigators an individually tailored program with research mentoring, didactic education, and formal career development programming to bridge their transition to academic independence. The program's ultimate goal is to develop diverse, highly trained, creative and productive independent investigators who are able to achieve their career goals in ophthalmology and vision research.